Radioimmunoassay and Biomarkers Core

The Radioimmunoassay and Biomarkers Core proposes to continue offering an increasing number of high-
quality immunoassay and biochemistry services to our evolving group of Diabetes Research Center (DRC) basic,
translational, and clinical scientists. Services over the last cycle have included radioimmunoassay (RIA),
enzyme-linked immunosorbent assay (ELISA), multiplex ELISA on the Luminex platform, high performance liquid
chromatography (HPLC) on the ThermoFisher platform, metabolite assays on the Yellow Springs Instruments
(YSI) platform, and most recently multiplex ELISA on the ELLA platform for an expanding variety of diabetes and
metabolism related hormones, cytokines, and metabolites derived from blood, urine, salivary and tissue samples.
These assay services have proven essential for current research in the DRC and Penn’s Institute for Diabetes,
Obesity & Metabolism (IDOM) and will remain an integral part of the future operation and development of the
Center and Institute. In the next cycle the RIA/Biomarkers Core will continue existing immunoassay serives
including RIA that are essential for cost feasibility of high sample number experiments, and expand services
beyond RIA, ELISA, Luminex, HPLC, and YSI platforms to include development of assays on a more sensitive
multiplex platform based on microfluidic ELISA (ELLA). ELLA technology will be used to implement accurate
multiplexing of cytokines with enhanced sensitivity and an expanded dynamic range required for understanding
the intersection of inflammation and metabolism in rodent and human studies, and so enhance the value of our
expanding assay services for DRC investigators. In addition, the Core will proactively engage in outreach to the
local research community of diabetes, obesity and metabolism investigators, while enhancing the QA/QC/QM of
the assay services provided. In addition, the RIA/Biomarkers Core will integrate delivery of new and existing
assay services to an expanding base of investigators via shared resources within the Smilow Center for
Translational Research. The Core is located on the 12th floor in IDOM and in near proximity to the Islet Cell
Biology, Functional Genomics, and Rodent Metabolic Phenotyping Cores that fosters close interactions among
these DRC Cores. The integrated delivery of assay services provided by the Core will be enhanced by further
development of informatics infrastructure for ordering, tracking, billing and delivery of service using iLab. The
performance of a large number of RIAs and ELISAs in a central core facility rather than in scattered locations
throughout the University provides a significant overall savings in equipment, personnel effort, and supplies for
our investigators, while importantly allowing for the generation of results with better quality due to our enhanced
quality control/quality assurance/quality management (QA/QC/QM) processes. We will continue collaborations
with other NIH-sponsored core resources and the School of Medicine at Penn in order to enhance and expand
the number of services available to our investigators, increase efficiency and technical expertise in the provision
of assay services, and continue to improve our throughput and data quality.